Unrecognized Primary Aldosteronism as a Pathogenic Mechanism for Chronic Kidney Disease in Diabetes

PROJECT ABSTRACT
Diabetes is the leading cause of chronic kidney disease (CKD). When combined, diabetes with CKD
exponentially increases risk for cardiovascular disease and death. Preventing or delaying CKD in diabetes would
substantially decrease these adverse outcomes, save billions in healthcare expenditures, and improve quality of
life for those at high-risk for dialysis-dependent kidney failure. Emerging evidence strongly indicates that primary
aldosteronism (PA) pathophysiology is a causative mechanism for the development and progression of CKD in
diabetes. PA pathophysiology is characterized by relatively non-suppressible and renin-independent aldosterone
production that causes excessive activation of the mineralocorticoid receptor (MR). This maladaptive activation
of the MR induces inflammation and fibrosis that contributes to CKD and cardiovascular disease.
Our work in R01DK115392 has re-defined primary aldosteronism. We have shown that PA
pathophysiology exists across a broad continuum of severity, from mild (or subclinical) to overt (or severe); in
this regard, PA is better considered to be a pathophysiologic syndrome. The prevalence of PA pathophysiology
is high and almost entirely unrecognized. Our work, and that of others, has demonstrated that PA
pathophysiology can be detected in 10-25% of the general population; however, despite this alarming
prevalence, the rates of testing for PA, or empiric MR antagonist use, in these high-risk populations is abysmal
and rarely exceeds 2%. The scope of this problem is magnified by the fact that randomized clinical trials in
patients with diabetes have established the exceptional efficacy of MR antagonists for reducing albuminuria,
lowering the risk of CKD progression, incident end-stage kidney disease, and incident cardiovascular outcomes.
Despite demonstrating this efficacy, these landmark trials did not investigate the role of PA pathophysiology. Our
results from R01DK115392 represent the most likely hypothesis to explain the reno-protective benefits of MR
antagonists: there is a prevalent, progressive, and unrecognized, spectrum of PA pathophysiology and MR
activation in people with diabetes that increase their risk for CKD.
In this renewal, we will extend our work in R01DK115392 by conducting a mechanistic cohort study to
deeply characterize PA pathophysiology and MR activation in individuals with diabetes and at-risk for incident or
progressive CKD. A thorough understanding of PA pathophysiology as an early mechanistic contributor to CKD
in diabetes will provide critical evidence to support broader use of MR antagonists to prevent CKD development
and progression in diabetes. Participants with diabetes and CKD3A, or at high-risk for developing CKD, will
undergo characterization of PA pathophysiology using profiling of steroids indicative of dysregulated aldosterone
synthase activity, measurement of urinary extracellular vesicles containing proteins indicative of pathology MR
activation, and large-scale unbiased proteomics to explore biomarkers of fibrosis and aldosterone-MR
interactions. Participants will be followed, and measures repeated longitudinally, for 3 years.

Public health relevance
PROJECT NARRATIVE Kidney disease is a common complication for patients with diabetes that can progress to kidney failure and death and our research has shown that the hormone aldosterone may play an important role in causing kidney disease in patients with diabetes. Since there are widely available medications that can prevent aldosterone- mediated kidney disease, it is critical to understand how aldosterone may cause diabetic-kidney disease. This proposal will investigate the presence of excess aldosterone among people with diabetes to characterize whether aldosterone-blocking medications may prevent kidney disease in this population.